Outreach Core

SUMMARY (AIM 3): OUTREACH CORE
The Outreach Core will coordinate activities aimed at the participating communities of research scientists,
clinicians, trainees and staff in the CSP Center, and engage a wider audience interested in the application of
systems pharmacology methods and multi-scale approaches to basic and translational cancer research and to
improving the way clinical trials are interpreted. The Center will host regular group meetings, invite seminar
speakers, and coordinate workshops and training programs to bring together investigators with diverse
expertise to address key questions and unmet needs in immuno-oncology and targeted cancer therapies. The
core will also establish methods for sharing data, models and methods with a wide range of users. Data
processing and release will involve `Sterile Technique' which uses software to manage data, move it into stable
on-line archives (Sage Synapse and the Open Microscopy OMERO platform). Programmatic management of
data and metadata is essential to maintain integrity, track provenance and reduce human-introduced error.
Aim 3.1 Will support a comprehensive program of seminars, workshops and bespoke training programs that
enrich the Center community, bring in new approaches and expertise, and train Center members and other
investigators in methods and resources relevant to cancer systems biology and pharmacology. This will include
topical seminars, workshops, think tanks and short-form course. Aim 3.2. Will promote Cancer Systems
Pharmacology as an approach to precision treatment of cancer through a website and other means, host
scientists from other NCI Centers, and engage students from historically under-represented communities in
cancer research. Aim 3.3 will create a multifaceted program with opportunities for cross-training, short-term
visits by scientists and trainees, and opportunities for high school students to engage in cancer research.
Participation in Science in the News at HMS will communicate the findings of the center to lay community
including patient groups via an established channel.